Support of Diversity Initiatives in the UCSF-Bay Area CFAR: Developing HIV Researchers from Pipeline to Early Career Faculty

PROJECT SUMMARY
This revision application to the UCSF-Bay Area CFAR aims to strengthen our support for diverse HIV
researchers or investigators who study disparities in HIV and foster investigators from the pipeline
(undergraduate/masters’ level students) to early career faculty, all through revisions to our Developmental
Core. Key initiatives include the CFAR Diversity, Equity, and Inclusion Pathway Initiative (CDEIPI) Scholars’
program, a mentored summer research internship for undergraduate/masters’ level students from a historically
minority-serving institution in San Francisco (Aim 1); a mentoring training program for underrepresented early
career investigators or those who study health disparities (Aim 2); and a career development award program
for faculty working with diverse populations or from underrepresented minority backgrounds (URM) (Aim 3).
The application’s overarching goal is to formalize and integrate successful diversity initiatives into the
Developmental Core, ensuring our sustained impact on creating a pipeline of investigators who can contribute
to ending the HIV Epidemic.
Our work proposes three aims. The first aim is to sustain and expand the CFAR Scholars Program, providing
mentored research experiences for local minority-serving institution students, particularly from
underrepresented backgrounds. We aim to leverage our mentoring infrastructure and emerging URM mentors
to make this a lasting program within our CFAR. The second aim is to support and train underrepresented
early career investigators in mentoring through the Mentoring the Mentors training program. This program,
specifically targeted to URM postdoctoral fellows and early career faculty, should improve mentor and mentee
outcomes and promote career development. Trainees in this designated mentoring program will be drawn from
our URM Mentoring Program, mentors of our CFAR Scholars (Aim 1), and the Inter-CFAR URM Working
Group we organize. Our final aim is to formalize the CFAR/ARI Career Development Program, supporting early
career faculty from URM backgrounds or working with diverse populations. This program, previously known as
the Diversity Scholar Award, has significantly contributed to the success of past awardees, aiding in grants,
publications, and retention. Each of these programs will be subject to rigorous tracking and evaluation of
outcomes and will be enhanced through repeated feedback cycles detailed in our Plan for Enhancing Diverse
Perspectives. Through these aims, we seek to build a diverse workforce, enhance mentoring capabilities, and
provide critical support for diverse early career faculty. These efforts align with the goals of the funding
announcement by addressing disparities in HIV research, fostering inclusivity, and contributing to improved
health outcomes for individuals living with HIV.

Public health relevance
PROJECT NARRATIVE This revision for the UCSF-Bay Area CFAR aims to strengthen our support for diverse researchers or disparity- based research in HIV studies, fostering a pipeline of skilled investigators addressing health disparities in HIV- affected populations. These initiatives include the CFAR Diversity, Equity, and Inclusion Pathway Initiative (CDEIPI) Scholars’ program (a mentored summer research internship for undergraduate/masters’ level students), a Mentoring the Mentors training program for early career investigators from underrepresented backgrounds, and a career development award program for early-career faculty working with diverse populations or from underrepresented backgrounds themselves. By promoting inclusivity in the HIV research pipeline, our CFAR can help contribute to better health outcomes for people living with HIV.